Population Dynamics Research Center

OVERALL: PROJECT SUMMARY
The goal under a new P2C award is for the Population Studies Center (PSC) at the U. of Pennsylvania to
remain a national and world leader in research on the dynamic structure, organization, and health and well-
being of human populations. Established in 1962, the PSC is characterized by strong continuity in the
production of high-quality research on the major themes of the Population Dynamics Branch (PDB):
demography, population-based studies of health and human development, and behavioral and social science
approaches to sexually transmitted diseases and reproductive health. The PSC will make substantive
contributions in five primary research areas (PRAs): (1) New Dynamics of Population Diversity, including
racial/ethnic composition, internal and international migration, and urbanization, (2) Formal Demography and
Demographic Methods, including fertility and reproductive health, and mortality, (3) Child Development and
Human Endowments, (4) Structures of Inequality and the Life Course, including changing mechanisms of
social mobility, and (5) Population and the Environment, addressing both the demographic causes and
consequences of environmental change. We will develop and promote emerging innovative research
perspectives and approaches within and across our PRAs. We will also increase competitiveness for external
funding in population dynamics research through intellectual exchange, partnership and outreach, and a seed
grant award program to support research innovation. A central aim of the PSC is to develop, mentor, and
promote emerging scientific, intellectual, and professional leaders in the field of population studies through the
effective use of PSC support, resources, and expertise directed to early career scientists.

Public health relevance
OVERALL: PROJECT NARRATIVE The Population Studies Center (PSC) at the U. of Pennsylvania provides critical infrastructure to generate innovative, interdisciplinary research on the economic, social, and environmental dimensions of population growth and structure that are central to health and well-being. The research supported by this award will inform the design of policies and interventions aimed at improving overall health and reducing health disparities.